NEURON SPECIFIC ENOLASE IN SERUM AS PREDICTOR OF HEAD INJURY SEVERITY

Subjects which are six hours post blunt head trauma admitted to ER will be eligible for this investigation. The investogator proposed to show that neuron sspecific enolase enzyme levels are a reliable predictor of the severity of head injury.